NMR strategies to probe allosteric effects of inhibitor binding on AML-associated Src-family kinases

The Src tyrosine kinase family has been validated as a target for drug development against many forms of
cancer including myeloid leukemias. A major clinical challenge with kinase-targeted drug therapy has been the
emergence of drug-resistant mutants that escape ATP-binding site inhibitors. To overcome this obstacle, the
Smithgall lab (co-I on this proposal), focuses on the development of complementary pairs of ATP-site and
allosteric inhibitors. This approach aims to enhance target selectivity and eliminate the potential for acquired
resistance. Protein NMR is an ideal method for characterizing conformational changes induced by both ATP-
site and allosteric inhibitor interaction in solution. Particularly, when an allosteric inhibitor binding site is
occluded in a crystal by the packing effect or cannot be co-crystallized, NMR serves a powerful and orthogonal
alternative method to crystallography. The goal of the proposed research, therefore, is to design a tailored
NMR strategy for investigating inhibitor-induced conformational changes in the Src family kinase Hck, which
has been implicated in the etiology of acute myeloid leukemia (AML). In Src family kinase, tryptophan residues
are located at several important sites. There are ~10 tryptophan residues in Src family kinase. They are mostly
conserved and positioned at key domain interaction sites. As shown for Hck, the indole amide signals are
observed without severe signal overlaps. We hypothesize that this unique characteristic will make Trp indole
resonances in Hck highly sensitive probes for investigating allosteric modulator effects on remote regions of
the protein (Aim 1). We also hypothesize that site-specific 19F detection will be a useful tool to observe
resonance changes in key Src-family kinase sites in response to ligand binding (Aim 2). We test these
hypotheses by performing NMR experiments. Based on results in both aims, we will formulate a
comprehensive NMR strategy for evaluating and categorizing allosteric conformational changes in Hck upon
small molecule interaction. Successful completion of this study will significantly advance the development of
both ATP-site and allosteric inhibitors targeting the AML-associated target kinase, Hck.

Public health relevance
Src tyrosine kinase family is a validated drug target in many forms of cancer. Our long-term goal is to develop effective inhibitors that enhance selectivity and eliminate the potential for acquired resistance. The goal of the proposed research is to design a tailored NMR strategy to investigate conformational changes of the Src family kinase, primarily for Hck, upon inhibitor interactions in solution. Successful completion of this study will significantly advance the development of both ATP-site and allosteric inhibitors targeting the AML-associated target kinase, Hck.